The University of Rochester's Clinical and Translational Science Institute

Project Summary
Translational research generates ethical questions that cross the boundary between clinical and research
ethics. Standard frameworks in research and clinical ethics do not provide adequate guidance to
researchers and clinicians attempting to navigate these complex questions. This project aims to build
capacity in translational ethics. In Aim 1 we establish an evidence base of the unique ethical
challenges faced by translational researchers. Using a mixed methods approach that incorporates
standard philosophical research with stakeholder interviews, we hope to identify the key ethical challenges
in translational research, the success or difficulty of applying standard clinical and research ethics
frameworks to those challenges, and points of intersection between clinical and research ethics. We will (1)
interview a cohort of 15 established translational researchers to identify common ethical challenges and
gaps in their training, (2) conduct a systematic review of the bioethical literature to identify and characterize
the strengths and gaps of adopting standard clinical or research ethics frameworks in the translational
context, and (3) generate an in depth philosophical case study on one such problem (i.e. the management
and study of patients with rare diseases) to sketch a framework for navigating ethical challenges that cross
the translational pipeline from basic science to clinical care. In Aim 2, we develop, pilot and evaluate the
Translational Ethics in Action Modules (TEAM) to improve capacity in bioethical reasoning amongst
emerging translational researchers. We will design a series of modules to develop capacity in bioethical
reasoning amongst the next generation of translational researchers. The modules will form part of a new
course at the University of Rochester for emerging researchers that is specifically focused on navigating the
dual ethical roles of health practitioner and scientist. This includes problems arising in translational research
such as appropriately judging equipoise, the therapeutic misconception, the clinical management of patients
with rare diseases, the ethics of secondary research using clinical data, and the balance between scientific
certainty and policy advocacy. The project will adopt a design-based research approach to developing and
evaluating the course, using qualitative interviews, iterative design and a pilot of the course in Spring 2024.
Successful completion of this project will result in (i) an evidence base of the unique ethical challenges
faced by translational researchers, (ii) a set of open-educational resources for training emerging
researchers in translational bioethics (iii) an evidence base for the effectiveness, sustainability and
attractiveness of those resources, and (iv) improved capacity in translational bioethics amongst a cadre of
emerging research leaders. We anticipate that our investigation of translational ethics will provide the
conceptual and pedagogical tools scientists and health practitioners need as they work to responsibly
generate knowledge and interventions that benefit patients and communities.

Public health relevance
Project Narrative The overall goal of this project is to build capacity in translational ethics, by investigating the ethical questions that arise during research projects that translate basic scientific findings into clinical or population health interventions. It will result in a series of educational modules designed to raise awareness and build the ethical competency of emerging translational researchers as they work to responsibly generate knowledge and interventions that benefit patients and communities.